Mevalonate Pathway Regulation of Astrocyte ApoE

Abstract
The ApoE 4 isoform is the strongest genetic link to Alzheimer’s disease for unclear reasons. ApoE is a lipid
carrying protein. Both the content of the ApoE particles and their release from astrocytes varies by ApoE
isoform. We have found that the mevalonate pathway can regulate both the release of ApoE from astrocytes
and the lipid content of those ApoE particles. Depending on the part of the pathway that we inhibit we can
separate these two functions.
We hypothesize that targeting individual components of the mevalonate pathway can be used to manipulate
the secretion and composition of ApoE in order to reduce Aβ synthesis and improve neuron survival. Further,
we will explore if reducing the lipid content of the ApoE particles, without impacting secretion of the particles,
can help shift the behavior of ApoE4 particles towards the behavior of lower risk ApoE genotypes.
Through the proposed experiments we will test if:
Aim 1. Secretion of ApoE is regulated via the mevalonate pathway in quiescent and activated
astrocytes in an isoform specific manner. There are 3 well-characterized isoforms of ApoE in humans; 2, 3
and 4, which carry varying risks for developing AD. The quantity and composition of lipids carried by ApoE is
influenced by ApoE genotype and astrocyte activation state. We will use mice expressing humanized ApoE 2,
3 or 4 or an ApoE knockout control to grow primary cultures of cortical astrocytes. Astrocytes will be grown in
serum-free media to mimic the quiescent state or treated with TNF, IL-1α and C1q to mimic the activated state.
Utilizing chemical inhibitors, shRNAs and conditional knockouts, we will determine the contributions of the
cholesterol and prenylation arms of the mevalonate pathway to regulation of ApoE secretion by astrocytes.
Aim 2. Inhibition of the mevalonate pathway can improve the abnormal lipid droplet accumulation and
lipid secretion profile in ApoE4 astrocytes. Using the tools from Aim 1, we will manipulate the mevalonate
pathway in astrocytes from ApoE knockout and ApoE 2, 3 or 4 knock-in mice. Intracellular ApoE and lipid
droplets will be assessed by confocal microscopy. The lipid composition of astrocyte conditioned media from
quiescent and activated astrocytes with and without inhibitors to cholesterol synthesis, prenylation or both will
be measured. Changes in cholesterol-lipid carrier interactions will be determined using a cholesterol probe.
Aim 3. Selective inhibition of the mevalonate pathway in astrocytes will reduce amyloid-beta cleavage
and neuron death. We predict that inhibition of cholesterol, while preserving prenylation, will reduce AD
pathology, with the greatest effect in ApoE4 astrocytes. Conditioned media from astrocytes treated with
inhibitors of cholesterol synthesis, prenylation or both will be applied to primary neurons. We will then measure
clustering of APP with lipid rafts by super resolution imaging, Aβ secretion by ELISA, activation of the
lipoapoptotic pathway by western and cell death by ethidium incorporation.

Public health relevance
Project Narrative ApoE is the strongest genetic risk factor for Alzheimer’s disease for unclear reasons. We have found that the pathway which regulates cholesterol metabolism also regulates the lipid content and release of ApoE from astrocytes in the brain. Better understanding how the different ApoE types are impacted by inhibiting this pathway could lead to better strategies for preventing or treating Alzheimer’s disease in the future.